Selective Functionalization of Aliphatic Amines - Supplement to Support Mariah Ramos

Principal Investigator: Rovis, Tomislav
Abstract
Recent years have brought about a greatly enhanced understanding of structure-activity relationships (SARs)
of biologically relevant compounds. Accordingly, there is a greater need for streamlined, complementary
syntheses to access practical drug scaffolds. Current methods focus on editing the periphery of drug
compounds to install versatile functional handles. Alternatively, altering the core of target molecules would
provide access to diverse drug scaffolds while leaving peripheral handles untouched. Direct core editing
would significantly decrease the design-synthesis-test time, as most drug core alterations require an entirely
new synthesis. This proposal describes an efficient synthetic route to access 1,2-diazepines from readily
available pyridines through dearomative ring expansion. Aim 1 outlines using previously established
methods to obtain the pyridinium ylide intermediate on multi-gram scale, the diazepine can be obtained
through a 6π electrocyclic ring opening upon irradiation with 370nm light. 1,2-Diazepines are among the
least common nitrogen heterocycles present in FDA approved drugs, likely due to the lack of synthetic
pathways that enable access to these scaffolds rather than their biological properties. While pyridine
expansions are generally multistep procedures, our work has shown promise for a one-pot route to this
expansion product. Additionally, Aims 2 and 3 propose novel, alternate methods of obtaining these valuable
products. A one-pot catalytic nitrene transfer with simultaneous irradiation could afford the 1,2 diazepine
and variants. Taken together, this proposal provides access to synthetically difficult drug cores, while also
introducing synthetic handles for further derivatization.
5

Public health relevance
Principal Investigator: Rovis, Tomislav Project Narrative This proposal describes a synthetic route to access 1,2-diazepines from readily available pyridines through dearomative ring expansion. Accessing novel scaffolds through an efficacious and promising method could provide new, diverse, and vital therapeutics for patients everywhere. 5